Elucidating the biological differences between distinct fibrillar and non-fibrillar alpha-synuclein inclusions in human stem-cell models

Project Summary
Aggregation of specific proteins within neurons and glia comprise the hallmark pathologies of neurodegenerative
diseases (ND) like Alzheimer’s (AD) and Parkinson’s disease (PD). In AD, the aggregating protein is b-amyloid
(Ab), and in PD it is a-synuclein (a-syn). Intriguingly, these two pathologies often coexist and the significance of
this is unknown. Many cellular defects are detected in the presence of a-syn mutations or overexpression,
prominently including defective vesicle trafficking. Outstanding questions remain—how does a-syn impart
toxicity, and how does it exert effects on a wide span of cellular pathways? How does stage of the pathology,
including the formation of distinct subtypes of a-syn inclusions, alter the vulnerability of the cell? What is the
connection between a-syn and the AD-linked protein Ab that is often seen to coexist in the brains of patients
with synucleinopathies? We previously conducted a genome-wide CRISPR/Cas9 screen for genetic modifiers of
a-syn toxicity in a human cellular model that captures advanced membrane-rich a-syn aggregates highly
reminiscent of human postmortem brain pathology in PD. We also conducted a targeted exome sequencing
screen in synucleinopathy patients, focusing on known modulators of both a-syn and Ab cytotoxicity.
Interestingly, top hits from both of these approaches converged on genes related to actin cytoskeleton regulation.
The convergence of hits from these two screens led us to hypothesize that a key aspect of a-syn toxicity relates
to altered actin cytoskeletal stabilization and that this may be a key point of convergence of both a-syn and Ab
cellular toxicity. Indeed, the actin cytoskeleton orchestrates organization of cellular organelles and substructures
and others have postulated its dysregulation may play a role in many of the a-syn- and Ab-mediated cellular
defects. Our genetic investigations in human cells and patients now pinpoint a specific set of genes that might
mediate this crosstalk between AD and PD pathologies. In this proposal, we aim to (1) examine whether the
actin cytoskeleton contributes to toxicity in synucleinopathy iPSC-derived neuron models, (2) conduct a pooled
secondary screen in iPSC-derived neuron models and validate genetic modifiers of a-syn toxicity, and (3)
examine whether a-syn-mediated actin cytoskeleton defects are modulated by Ab to understand the
convergence between a-syn and Ab toxicity. Understanding the molecular and genetic underpinnings of PD, and
any possible connection with AD, will ultimately contribute to a better grasp of the disease and help uncover
novel therapeutic targets.

Public health relevance
Project Narrative Parkinson’s disease (PD) is a devastating and incurable chronic neurodegenerative disorder affecting nearly 10 million people worldwide. Mysteriously, patients with PD often exhibit Alzheimer-like pathology in the brain and the significance of this is not understood. In this proposal, we investigate the connections between Parkinson and Alzheimer pathology, taking our lead from recent genomic sequencing studies and investigations within a novel stem-cell model we developed.